Membrane cholesterol homeostasis in human brain cells derived from iPSCs

Alzheimer’s disease (AD), a major form of dementia, starts with synaptic dysfunction and progresses to massive
neurodegeneration. Mutations of amyloid precursor protein (APP) that increase amyloid plaque (one of the two
AD hallmarks) are found in the very rare familial AD (fAD, a.k.a. early-onset AD or EOAD). The discoveries of
mutations in PSEN1/2 that make amyloid peptides from APP reinforce the amyloid hypothesis, positing that A
(-amyloid peptide) aggregation causes synaptic dysfunction and neurodegeneration. There are many other risk
factors have been discovered through genomic screen of thousands of patients with sporadic AD (sAD),
highlighting that the cause of AD is likely multifactorial. Early studies about APP led to various theories about its
functions, ranging from neurodevelopment to apoptosis. But the link between APP and AD remains elusive other
than A. Very recently, our work in mouse neurons led to an intriguing discovery – APP and cholesterol (Chol)
are inversely correlated in the plasmalemma of presynaptic terminals. Moreover, point mutations within APP’s
Chol-interactive motif (CIM) causes APP increase and Chol decrease at the plasmalemma of axon terminals.
Chronically, those mutations led to abnormality in synaptic vesicles (SVs), swollen synapses, disintegrated axons
and tau hyperphosphorylation. Hence, we postulate that APP regulates presynaptic Chol and that APP mutations
triggers neurodegeneration by disrupting neuronal Chol homeostasis. In fact, a lot of evidence supports a close
tie between Chol and AD: (1) ApoE4, the highest genetic risk factor for sAD is an isoform of Apolipoprotein E
and it often accompany with abnormal lipid metabolism in the brain; (2) brain Chol metabolism declines during
aging, the primary risk factor for AD; (3) mutations found in Niemann-Pick Type C1 disease interferes with Chol
supply to plasmalemma and cause “juvenile AD” phenotype in the mouse model; (4) APP intracellular domain
cleaved off by -secretase serves as a suppressor for the expression of lipoprotein receptor; (5) both APP and
Chol are concentrated at axon terminals and crucial for synaptic plasticity, the biological basis for learning and
memory. Here, we will test the hypothesis that mutations affecting APP distribution, trafficking, and interaction
with Chol triggers synaptic dysfunction and neurodegeneration via disrupted presynaptic Chol homeostasis. To
do so, we will use human neurons differentiated from induced pluripotent cells (hiNs) for better clinical relevance.
Methodologically, we will employ new imaging tools and electrophysiological recording] to systematically
investigate APP, Chol, synaptic transmission, plasticity and cell pathology. If successful, this project will provide
new insights about APP’s intrinsic function, the importance of presynaptic Chol, and, more importantly, the cause
of AD, which will lend a hand to new therapeutic strategies for AD.

Public health relevance
Repeated failures of A-reducing drugs provoke the reconsideration of APP’s function and disease relevance. Here, we will investigate APP mutations associated with inheritable Alzheimer’s disease in the context of neuronal cholesterol homeostasis. Supported by ample empirical and clinical evidence, this study will bring new insights about APP’s intrinsic function and pathogenic contribution, which will surely lead to new therapeutic treatment and preventative strategy.